TCR-dependent and epigenetic mechanisms guiding influenza-specific CD4+ T cell responses in the lung

ABSTRACT
CD4+ T cells mediate protection from influenza infection in mice and humans and represent a potential target of
vaccination. While influenza-specific T cells may be generated via immunization or viral infection, how the nature
of initial antigen exposure shapes the formation, persistence and function of the subsequent CD4+ T cell
response to influenza infection is not fully understood. The long-term objective of our research is to determine
the TCR-dependent and epigenetic mechanisms that drive secondary CD4+ T cells responding to influenza
infection. We recently published a collaborative study showing that CD4+ T cell responses to influenza are
shaped by prior antigen exposure. We adopted a sequential heterologous immunization approach in which
CD4+ memory T cells generated via either infection or protein immunization are rechallenged with influenza
virus. Both infection- and immunization-induced CD4+ memory T cells undergo extensive secondary expansion
following influenza infection, leading to the formation of long-lived and abundant secondary CD4+ memory T
cells, both in circulation and in the lung, as well as enhanced germinal center responses. The function of the
secondary response in the lung is guided by the primary challenge. Primary activation of CD4+ T cells via protein
immunization biases the lung CD4 secondary response to influenza towards Tfh function, whereas primary CD4+
T cell activation via infection biases the lung CD4 secondary response to influenza towards Th1 function. Our
preliminary data indicate that CD4 effector T cell responses in the lung are also biased towards high TCR
signaling and high affinity, as compared to the draining lymph node, suggesting that strong TCR signals may be
required to sustain effector responses and drive the formation of large numbers of secondary CD4+ memory T
cells. Additionally, we previously reported that the functional differentiation of CD4+ T cells in response to acute
infection is controlled epigenetically by acquisition of DNA methylation programing, with the opposing effects of
the DNA methyltransferase DNMT3A and the methylcytosine dioxygenase TET2 determining differentiation
outcome and memory T cell plasticity. Therefore, we will test the overall hypothesis that TCR signal strength and
epigenetic DNA methylation programming guide the function and long-term memory of the secondary CD4 T cell
response to influenza infection. Our aims are to: 1) Determine the relationship of TCR signal strength and TCR
antigen-binding kinetics, including affinity and bond lifetime under force, to secondary CD4+ T cell differentiation
in the lung; and 2) Define the role of TET2- and DNMT3A-dependent epigenetic programming established during
primary T cell activation in driving secondary effector function in response to influenza challenge.

Public health relevance
Narrative T cell responses to influenza are subject to multiple antigen exposures, both via vaccination and infection. The goal of this proposal is to determine how the nature of a primary antigen exposure influences the ability of T cells to respond to subsequent influenza challenges. We propose that a better understanding of how to induce long-lived immunity to influenza mediated by T cells will aid in the development of better vaccination strategies.